Efficacy of Precision Text Messaging to Increase Physical Activity in Insufficiently-Active Young Adults

PROJECT SUMMARY
Physical activity and weight management are key components of ideal cardiovascular health but many young
adults are insufficiently active and gaining weight rapidly (0.5-1.0 kg/year on average). Physical activity is a
proven strategy for attenuating weight gain so there is a pressing need for effective interventions that reduce
cardiovascular risk by motivating people to move more, sit less, and reduce weight gain. Mobile and wearable
technologies are nearly ubiquitous among young adults and provide access to dense digital data about the
person and their environment. This technology also provides a means of delivering interventions on a just-in-
time basis so each person can receive the right intervention content at the right time. Inspired by the vision of
precision behavioral interventions, we have applied system identification tools from control systems
engineering to develop computational models and algorithms that optimize person-specific dosing of text
messages to promote physical activity. In a series of preliminary studies, we (a) identified weather indices
consistently linked with physical activity, (b) demonstrated the feasibility of long-term activity tracker wear and
the acceptability of text messages among young adults, (c) enriched our computational model of physical
activity using momentary weather data to characterize weather-graded responses to messages, and (d)
designed a controller that uses person-specific parameters from the computational model and data on recent
behavior and forecasted weather conditions to optimize the selection and timing of text message delivery. This
controller is the basis for the Precision Adaptive Intervention Messaging (Precision AIM) intervention. In this
application, we propose a single-site clinical trial to answer question, “Does Precision AIM increase
insufficiently-active young adults’ physical activity and reduce weight gain more than randomly-assigned
intervention messages (Random AIM) from the same message library or an activity tracker with no assigned
intervention messages (No AIM)?” The specific aims of this project are (1) to evaluate the efficacy of Precision
AIM compared to Random AIM and No AIM for increasing physical activity and reducing weight gain in
insufficiently-active young adults, and (2) to identify characteristics of participants who respond more to
Precision AIM than Random AIM or No AIM. We propose a three-arm randomized controlled trial to achieve
these aims. Insufficiently-active young adults will receive a consumer activity tracker and be randomly
assigned to one of three groups: Precision AIM, Random AIM, or No AIM. The intervention period will last for
12 months with a maintenance assessment at 18 months. The primary outcome is average daily step counts
based on accumulating evidence that increasing this readily-interpretable and widely-available metric reduces
cardiovascular risk in adulthood (assessed at baseline, 3, 6, 12, and 18 months). If successful, the underlying
algorithmic analyses informed by dense data from wearable devices will provide a new and scalable approach
for using consumer wearables in primordial and primary prevention of cardiovascular risk in young adults.

Public health relevance
PROJECT NARRATIVE Physical activity helps to prevent weight gain and preserves cardiovascular health yet many young adults do not meet federal guidelines for aerobic physical activity and gain weight. Smartphones and wearable activity trackers create new possibilities for promoting young adults’ physical activity and preventing weight gain. This project evaluates the efficacy of Precision AIM, a digital intervention that makes person-specific, context- sensitive dosing decisions to ensure each person receives the right message content for them at the right time.